Biostatistics and Bioinformatics Core

The Biostatistics and Bioinformatics Core, Core III, will facilitate translational research in prostate cancer, by providing UCLA investigators and their colleagues with state of the art biostatistical, bioinformatics, data management and clinical trials support. The core provides a centralized network of biostatistics/bioinformatics support and data management for prostate cancer researchers at UCLA and their collaborators. The overall goal of the Core is to provide statistical and data management support to basic and clinical investigators in the SPORE. This includes provision of power analyses for planning of preclinical and clinical studies and statistical analysis of all completed studies prior to publication. The Core also provides analytical services for all genomics research, including sequencing and gene expression arrays within the SPORE. In addition to these statistical services, the Core plays a central role in the management of the UCLA Prostate Cancer SPORE clinical database. The Core had designed and manages the web-based Prostate SPORE clinical database. Continual improvements to the database have been made to facilitate data input and workflow, as well as to provide a seamless environment for statistical and other inquiries. The database is linked to the biospecimen repository, as well as to the tissue arrays managed by the Pathology Core. The Core aims to provide comprehensive statistical consultation and analysis to the individual projects to SPORE investigators. This will also include education in the use of statistical software, preparation of manuscripts, and development and submission of new grant applications. It aims to provide a facility and computational leadership to design and carry out projects using high-dimensional technologies including tissue array, microarray gene expression, flow cytometry. Software and up-to-date statistical methodology will also be provided. It aims to maintain and develop a central data repository and provide data management/quality control activities for all SPORE projects and cores. This function will include development and application of additional data management and statistical programming tools.

Public health relevance
An important reason for having a core dedicated for statistical support is the complexity of the statistical issues involved in the proposed SPORE research. When standard statistical methodology does not apply, new statistical and bioinformatics methods must be explored. Effective data management and reporting are a crucial precursor to high quality and reproducible statistical analyses and for sharing data with the research community